OUTCOME OF SURVIVORS OF EXTRACORPOREAL MEMBRANE OXYGENATION

The objective of this retrospective, descriptive study is to gather information about the neurodevelopmental outcome in survivors of ECMO from 979-1987. General health, developmental status, and family interview for information regarding family functioning will be evaluated. Neurodevelopmental status of near age sibling or SES children will provide control data.